Frontiers in Fundamental and Translational Immunology

PROJECT SUMMARY
This proposal seeks support to establish an innovative multi-thematic postdoctoral training program in
fundamental and translational immunology to address the role of innate and adaptive immune cells in various
disease contexts. Emphasis is placed on understanding the cellular and molecular basis of immune cell
activation in the appropriate context of an immune response to infectious organisms and toxins, or the
dysregulation that occurs in the context of chronic inflammation and autoimmunity. These fundamental insights
provide the basis for novel therapeutic approaches in infectious disease, autoimmunity and cancer that will be
tested in pre-clinical models. Sanford Burnham Prebys Medical Discovery Institute (SBP) recently implemented
its 10-year strategic vision, which focuses on four disease priorities (cancer, autoimmunity, metabolic and
neurological disorders) and four cross-cutting scientific themes including epigenetics, metabolism, proteostasis
and immunomodulation. The proposed Program is an important element of this vision as we strive to provide
the best training environment for postdoctoral scientists interested in immunology research. Scientific research
at the Institute is supported by an infrastructure that includes multiple core facilities, thereby providing access
to advanced technologies and expert, dedicated personnel. SBP emphasizes a collaborative approach to
biomedical research, where teams of scientists with expertise in the biological sciences work together with
chemists, structural biologists, engineers, and computational biologists to achieve synergistic
accomplishments. This collaborative approach to science is intimately integrated into the culture of the
Institute, as demonstrated by the fact that ~30% of all SBP publications are the result of inter- and intra-
programmatic collaborations. Notably, 35% of over 500 publications from the preceptors' laboratories are led
by postdoctoral trainees who serve as first authors. Postdoctoral trainees in this T32 will join one of 13
research groups focused on aspects of immunology. The trainees will be guided by mentoring committees
focused on promoting scientific progress and career development. Seminar programs, workshops, retreats and
journal clubs will enrich research training. The trainees will be selected based on scientific and academic
accomplishments, suitability for research projects in the thematic areas and commitment to a scientific career
that builds upon the postdoc experience. Trainees will be supported for an average of 2 years, but will remain
with the program upon achieving independent support. The Program will support three trainees within the
network of postdoctoral researchers at SBP. It is expected that matriculants who have completed this Program
will have received a well-rounded training experience in cutting-edge patient-focused immunology research
and will be well prepared to embark on a variety of independent research and research-related careers in
fundamental and translational immunology.

Public health relevance
PROJECT NARRATIVE Our Program provides a research environment for our trainees to address emerging topics in fundamental and translational immunology; interfacing basic research with advanced technological disciplines and early stage drug discovery efforts supported by state-of-the-art core facilities.